Assessing Transporter-Mediated Natural Product-Drug Interactions Using a Translational Research Approach

PROJECT SUMMARY
Sales of botanical dietary supplements in the United States have steadily increased since passage of the Dietary
Supplement Health and Education act in 1994, nearing $10 billion annually as of 2019. As sales of these natural
products continue to rise, the need to characterize the risk of co-consuming them with conventional drugs is
imperative. Like drug-drug interactions, common pharmacokinetic mechanisms underlying natural product-drug
interactions include inhibition of drug metabolizing enzymes and/or transporters by the precipitant natural
product. Such interactions lead to altered systemic and/or tissue exposure to the object drug, which can result
in suboptimal pharmacologic or toxic effects. Unlike for drug-drug interactions, recommended approaches for
assessing pharmacokinetic natural product-drug interactions remain scarce, particularly for transporter-mediated
interactions. Results from the applicant’s recent clinical pharmacokinetic study showed that the botanical dietary
supplement goldenseal significantly decreased the systemic exposure to the anti-diabetic drug metformin in
healthy volunteers (by 23%). This compelling observation, along with complementary data from cell-based
transporter inhibition assays, the working hypothesis is that goldenseal inhibits the uptake transporter organic
cation transporter (OCT) 1 in the intestine to reduce metformin absorption. Based on the collective evidence, a
set of follow-up mechanistic studies is proposed that involve established in vitro systems, physiologically-based
pharmacokinetic (PBPK) modeling and simulation, and a proof-of-concept clinical study in a relevant patient
population (type 2 diabetics). Solubility and permeability parameters for the major alkaloids (berberine and (−)-
β-hydrastine) typically present in goldenseal products will be determined using simulated human intestinal fluids
and Caco-2 cell monolayers, respectively. These experimentally obtained absorption parameters, along with
other input parameters obtained from the literature, will be incorporated into a mechanistic PBPK model, which
will integrate intestinal OCT1 with other metformin-relevant transporters, to further characterize the goldenseal-
metformin interaction. An established dissolution/absorption/metabolism model will be used as the framework to
develop the PBPK model, which will allow for greater mechanistic insights into potential changes in intestinal
processes when virtual diabetic subjects are exposed to goldenseal products. A clinical study will then be
conducted to verify model prediction accuracy and to determine the clinical relevance of these pharmacokinetic
changes in type 2 diabetic patients. The proposed translational project will be the first of its kind to develop a
PBPK model for elucidating transporter-mediated natural product-drug interactions. The knowledge gained from
these efforts will ultimately build upon a systematic framework for effectively studying other potential transporter-
mediated natural product-drug interactions.

Public health relevance
PROJECT NARRATIVE Drug interactions account for more than 190,000 hospitalizations in the United States annually, which is estimated to incur $30 billion in healthcare-related costs. Botanical dietary supplements and other natural products can precipitate drug interactions, which can lead to altered systemic and/or tissue exposure to the object drug, resulting in suboptimal pharmacologic or toxic effects. The proposed translational research project will (1) elucidate the transporter-mediated mechanism underlying the pharmacokinetic interaction between the botanical dietary supplement goldenseal and anti-diabetic drug metformin, (2) provide evidence-based clinical recommendations to mitigate drug interaction risks, and (3) contribute to the development of a comprehensive strategy for effectively assessing other potential transporter-mediated natural-product drug interactions.